Harnessing the power of social support for weight management: a randomized controlled trial of HealthyTogether

Background: More than 80% of VA users have body mass index (BMI)>25kg/m2, which contributes to
morbidity and mortality. Yet only 9% of eligible Veterans participate in VA’s national MOVE! Weight
Management Program, of whom only 20% achieve clinically meaningful weight loss (5%), underscoring
MOVE!’s limited reach and effectiveness. Limited effectiveness may be due to the focus on individual behavior
change without addressing the social and physical environments in which those changes occur. We developed
HealthyTogether – a brief, virtual weight management intervention integrating partners (e.g., spouses, family,
friends) into MOVE! programming combined with evidence-based dyadic communication and relationship skills
training. In a pilot study, HealthyTogether was feasible and acceptable to Veterans and partners and led to
improvements in weight and health behaviors. We propose to test HealthyTogether’s effectiveness and identify
barriers and facilitators to implementation in a two-site hybrid type 1 effectiveness-implementation study.
Significance: Maintaining a healthy weight, being physically active, and eating a balanced diet substantially
reduce premature mortality. However, few Veterans meet these recommendations, and VA’s MOVE! Weight
Management Program only produces clinically meaningful weight loss in 2% of eligible Veterans. Therefore,
additional effective, feasible, and scalable approaches that improve health behaviors and weight are needed.
HealthyTogether leverages Veterans’ social relationships and uses an existing VA workforce with the skills to
deliver the intervention. If effective, HealthyTogether could expand existing MOVE! offerings, reach more
Veterans, and grow the VA workforce addressing health behaviors and obesity. The proposed project aligns
with HSR portfolio topic areas of Primary Care Practice and Management of Complex Chronic Disease and
Access/Virtual Care, and contributes to the Quintuple Aim framework of improving outcomes and access.
Innovation & Impact: Our study is one of the first to systematically incorporate partners, defined broadly to
include a variety of relationships, to improve weight management outcomes and draws upon current, highly
relevant interpersonal theories to enhance effectiveness. It is also one of the first fully virtual dyadic weight
management interventions, reducing barriers to participation. If effective, HealthyTogether has the potential to
be integrated into MOVE! programming to improve weight management outcomes.
Specific Aims: 1) Test whether HealthyTogether results in greater weight loss than usual care at 6 months
among Veterans (primary); 2) Examine differences between HealthyTogether and usual care groups in
secondary Veteran and partner outcomes, including health behaviors (diet and physical activity) and
relationship quality; 3) Examine Veteran and partner contributions to changes in their own and each other’s
outcomes using dyadic analyses; 4) Assess determinants of implementation, including cost, fidelity, feasibility,
acceptability, and appropriateness, to inform future implementation.
Methodology: Using a hybrid type 1 effectiveness-implementation design, we will randomly assign N=152
dyads, consisting of a VA Puget Sound or Eastern Colorado patient with BMI>25kg/m2 and an adult partner, to
HealthyTogether or usual care 1:1. Over 8 weeks, intervention group participants will receive 6 weekly, hour-
long sessions and two brief check-ins, delivered through VA Video Connect by a clinical psychologist, social
worker, or trainee. The primary outcome is Veteran weight change at 6-months, assessed remotely, with
secondary outcomes of Veteran and partner health behaviors and relationship quality self-reported on web-
based surveys. Guided by the Consolidated Framework for Implementation Research, we will assess
implementation determinants, including via semi-structured interviews with VA staff and leadership.
Next Steps/Implementation: If effective, we will work closely with operational partners, including VA National
Center for Health Promotion and Disease Prevention, to identify appropriate implementation strategies.

Public health relevance
Four in five Veterans have overweight or obesity, yet only 2% of eligible Veterans achieve meaningful weight loss in VA’s national MOVE! Weight Management Program. Because close others (e.g., family and friends) strongly influence one’s health behaviors and weight, including them in weight management to better support health behavior change may improve weight management outcomes. Few such interventions have been tested, particularly those that use current, relevant dyadic theory to guide intervention development; include dyads who are not spouses or do not live together; and are delivered virtually to enhance access. The proposed study seeks to determine whether a brief, virtual, dyadic weight management intervention that includes Veterans and a close other leads to greater weight loss, compared to usual care, among Veterans with overweight or obesity. We will also collect important information on the barriers and facilitators to implementing the intervention in VA, which will inform future efforts to integrate it into clinical care.